Impact of large-scale genomic data on statistical and quantitative genetics

DESCRIPTION (provided by applicant): Support is requested for US invited speakers and selected contributing participants at the Impact of Large-Scale Genomic Data on Statistical and Quantitative Genetics (SQG) symposium to be held in Seattle, WA during November 25-26, 2013. SQG will be a comprehensive survey of the current status of statistical and quantitative genetics. New technologies in areas ranging from genomics and molecular genetics to statistics are providing both opportunities and challenges for our understanding of the genetic basis of quantitative traits in human and other natural populations. The invited speakers are all leaders in the led, with recent publications in high-impact journals. They are developing new statistical methodologies and applying them to large-scale genomic data. Support from this award will enable outstanding graduate students and postdocs to present their research and network with senior researchers.

Public health relevance
The field of genetics now has access to data on the complete DNA sequence of the genome of human and other organisms, as well as other high-dimensional -omic data. Interpreting these data and exploiting them for the betterment of the human condition requires new statistical methodologies, and the University of Washington, itself a leader in biostatistics, genome sciences and statistics, will host a conference to discuss the impact of large-scale genomic data on statistical and quantitative genetics. Leaders in the field have accepted invitations to present new methods and report on the applications of those methods to large-scale genomic datasets at a conference that is expected to attract professionals and students across a broad range of areas of genetics and its applications.